Quantitatively Characterizing the Speech Motor Skillsets of Individual Speakers

PROJECT SUMMARY
The overall goal of this project is to develop and test a neurocomputational model characterizing the speech
motor skills of individual talkers in a way that captures key speech motor control processes, namely auditory
feedback control, somatosensory feedback control, and feedforward control. In addition to assessing the model’s
fits to behavioral data, we will also test hypotheses concerning the relationships between neural measures and
model parameters. Our goal will be achieved through a tight coupling of computational modeling and behavioral,
neurostimulation, and neuroimaging experiments, organized into two specific aims involving the same three
participant cohorts: adults with persistent developmental stuttering, adults with dyslexia, and neurotypical adults.
Aim 1: Assess the specificity and reliability of model parameter fits to individual subjects
This aim assesses our model’s ability to characterize the speech motor skillsets of a broad range of participants
who will perform a series of behavioral experiments probing speech motor control mechanisms. Each participant
will perform two behavioral sessions on different days, during which their responses to reflexive and adaptive
auditory and somatosensory perturbations applied during speech will be measured. Subject-specific model fits
will be created for each protocol in each session, and the reliability of model parameter estimates across
protocols and sessions will be assessed to verify the model’s ability to meaningfully account for individual
differences. Predictions regarding group differences also will be tested, and computational modeling will be used
to assess model fits and compare them to alternative control schemes.
Aim 2: Identify neural correlates of individual-specific model parameters and assess their reliability
This aim involves two studies that test predictions derived from our neurocomputational model. The first study
uses magnetic resonance imaging to test for predicted correlations between neural measures (including
structural and functional connectivity measures) and model parameters. The second uses transcranial direct
current stimulation (tDCS) applied to hypothesized auditory and somatosensory feedback control centers to test
predictions regarding the function of these centers and their relationship to model parameters. These
experiments will provide crucial data regarding the neural subsystems underlying speech motor processes.
Successful completion of our aims will result in the first quantitative, neuroanatomically grounded model that
reliably characterizes the speech motor skillsets of individuals, including those with communication disorders,
thereby constituting a crucial step toward translating cutting-edge science into individualized treatments for motor
speech disorders. We will also determine how the motor skillsets of individuals with stuttering and dyslexia differ
from those of neurotypical speakers. Finally, these studies will further clarify the relationships between brain
function and speech motor behaviors characterized by the DIVA neurocomputational model.

Public health relevance
NARRATIVE This project will improve our understanding of how the brain controls speech production and will allow us to characterize an individual’s speech motor skills in a way that could be used to guide individualized treatments for a range of speech and voice disorders, which would profoundly impact the quality of life of millions of people.